Administrative Core

The Administrative Core will provide central coordination in support of this distributed program. It will monitor
progress and promote exchange of results and technology by organizing monthly team video-conferences and
annual face-to-face meetings. To provide oversight and critical feedback, it will organize regular meetings with
the Internal Advisory Committee and External Advisory Board. With guidance from the Internal Advisory
Committee and External Advisory Board, it will support inter-lab visits by team scientists to distribute technical
approaches and promote consistency across experiments in different labs. In addition, it will implement and
support a program web site to support team operations and disseminate information, software, and data to the
broader neuroscience community.